Housing assistance, Outcomes, Medicare, and SEER (HOMES): using a novel data linkage to understand cancer inequities

Project Summary
Socioeconomic and racial disparities in cancer care and outcomes among older adults have been persisted
and even widened in recent years. At the same time, the lack of safe and affordable housing has become a
national crisis. Despite the strong potential for housing insecurity to impact cancer inequities, there is a paucity
of evidence connecting these two areas. The Housing assistance, Outcomes, MEdicare, and SEER
(HOMES) Study is a highly innovative investigation of the association between housing insecurity and cancer
inequities. It focuses on the role of federal housing assistance which, through a variety of programs, including
Housing Choice Vouchers, public housing, and multifamily housing, limit household spending on rent and
utilities. By increasing housing affordability and stability, improving housing quality, changing neighborhood
context, and connecting residents with health and social services, federal housing assistance has the potential
to improve the quality of care that patients with cancer receive and, more broadly, shed light on the intersection
of cancer and housing. The study focuses on older adults diagnosed with breast, colorectal, prostate, and non-
small cell lung cancers given their high incidence and well-documented inequities. The study makes use of a
novel dataset being constructed by the National Cancer Institute that merges linked SEER-Medicare data on
patients diagnosed (2006-2019) with U.S. Department of Housing and Urban Development data on the receipt
of federal housing assistance. Because individuals who receive housing assistance may be fundamentally
different from those who do not, the study makes use of an innovative pseudo-waitlist control design that
leverages the limited supply of housing assistance relative to demand and the random timing of the receipt of
housing assistance. The first aim examines the overall relationship between receipt of federal housing
assistance and cancer care (time to treatment, receipt of guideline concordant care, emergency department
visits) and outcomes (stage at diagnosis). The second aim investigates whether these relationships vary by
cancer site and, given experiences of systemic racism that intersect with cancer disparities and housing policy,
by race/ethnicity. The final aim studies whether the association between housing assistance and cancer care
and outcomes varies by the form of housing assistance and across different neighborhood contexts. Informed
by a policy advisory committee in conjunction with representatives from the American Cancer Society Cancer
Action Network and National Cancer Roundtables, the HOMES Study has the strong potential to provide
actionable housing and cancer policy recommendations and inform changes to practice designed to improve
cancer equity.

Public health relevance
Project Narrative Safe and affordable housing provides a critical foundation for health; however, its relationship with cancer care and outcomes is largely unknown. This study examines whether patients with cancer who receive federal housing assistance are more likely to receive timely, guideline-concordant care for breast, colorectal, prostate, and lung cancers compared to similar patients without housing assistance.